Prevalence effects in visual research: Theoretical and practical implications

Low prevalence searches form an important and problematic class of visual search tasks. These are
tasks where the search target is rare. Many socially important tasks like airport security or cancer
screening are low prevalence tasks. Previous work, much of it from our lab, has shown that low
prevalence can have undesirable effects. Most notably, miss (false negative) errors are markedly
elevated at low prevalence. This is a clear problem if the purpose of the search is to detect something
rare but important like cancer or a terrorist threat. Our previous work has documented this pattern of
increased miss errors in a number of expert domains including cytology (cervical cancer screening),
airport baggage screening, and breast cancer screening. False alarm (false positive) error rates typically
decline at low prevalence, moving in the opposite direction from miss errors. This indicates a shift in the
observer’s decision criterion. At low prevalence, observers become more reluctant to call something a
target. Several studies – ours and others - have shown that this “conservative” criterion shift is not
adequate to explain the entire prevalence effect. Wolfe and VanWert (2010) developed a “Dual-
Threshold” model that better captures the important aspects of the prevalence effect data by proposing
two effects of low prevalence: (1) the conservative shift in the criterion for deciding if an attended item
is a target, and (2) a lowering of the “quitting threshold.” The quitting threshold determines when
observers end a search. Quitting too soon also increases the chance that the observer will miss a target.
Prevalence effects have been studied in experimental isolation from other aspects of search. However,
in tasks like breast cancer screening, other factors interact with prevalence. The four projects in the
present proposal each investigate one of these interactions. Project 1 examines the relationship of
prevalence to the “vigilance decrements” that are seen as time elapses in a task. In search, observers
must maintain an internal, mental representation of the search target (or targets). Project 2 is concerned
with the impact of prevalence on these “target templates”. Advances in artificial intelligence (notably
deep learning) are producing tools to assist expert searchers. However, once deployed, these AI tools
have been less effective than theory predicts. Project 3 tests the hypothesis that part of the problem is
another side-effect of low prevalence and the project tests a potential intervention. Finally, clinicians,
searching for one type of target (e.g. pneumonia) are supposed to report signs of other possible
problems (e.g. lung cancer). Project 4 probes the role of prevalence in the failure to report such
“incidental findings”. Again, we test several interventions. This is “use-inspired, basic research” whose
results will provide guidance for experts performing socially important low prevalence tasks.

Public health relevance
Important tasks like breast cancer screening involve visual search for rare (“low prevalence”) targets but, unfortunately, low prevalence is known to increase the percentage of targets that are missed even by well-trained experts. In a task like breast cancer screening, prevalence interacts with other factors like observer vigilance or the effectiveness of an artificial intelligence tool. This proposal studies four of these interactions with the goal of counteracting the malign effects of prevalence; thus making it possible for experts to perform their critical search tasks more effectively.